Next-gen 3D Modeling of Endoscopy Videos

ABSTRACT
Endoscopy plays a vital role in the diagnosis and treatment of various medical conditions and is regularly
performed millions of times every year. However, endoscopy is challenging in the context of narrow and
winding pathways within the body, resulting in incomplete surveys with several ‘blind spots’, and patient
discomfort. Researchers have explored various techniques that can assist physicians to perform more efficient
endoscopies by enabling better visualization, guidance back to unsurveyed regions, and semi-autonomous
procedures. However, these techniques are still clinically infeasible since the required 3D organ reconstructions
and endoscope localization is still far from solved. Post-procedure analysis of endoscopic videos to extract and
detect meaningful geometric properties, e.g. time-varying measurement of upper-airway cross-sectional area, is
also challenging and time-consuming for physicians to perform, and can be automated with 3D reconstruction.
Existing approaches for 3D reconstruction from endoscopy videos are primarily based on Simultaneous
Localization and Mapping (SLAM) techniques, which are unreliable when faced with typical characteristics of
internal organs, such as lack of geometric features, mucus layer reflections, and deformable surfaces. Existing
approaches have success rates as low as 40-50% for static shapes. Even these low success rates mostly only
apply to easy axial frames and 3D reconstructions may completely fail for deformable surfaces.
The goal of the proposed project is to develop a novel 3D reconstruction and localization system that can
effectively handle axial and non-axial frames for static and dynamic organs. We propose to develop deep neural
network-based computer vision algorithms that can generate 3D meshes from endoscopy videos and determine
the position and orientation of the endoscope in near-real time. Our proposed methodology leverages the
reflection of the endoscope's light to help recover an organ's shape, along with camera motion (Aim 1), and
models time-varying organ deformations (Aim 2). Our focus will be on reconstructing the respiratory tract and
colons. However, our approach is entirely general and will apply to other endoscopy reconstructions. We will
evaluate our approach on synthetic and real data, validating the results by working with clinical collaborators.
In summary, our proposed next-generation 3D modeling system aims to revolutionize endoscopy by providing
accurate 3D reconstructions and localization of both static and deformable organs. This advancement has the
potential to enhance patient comfort, improve diagnosis accuracy, and enable a wide range of downstream
applications in the field of endoscopy, e.g. semi-autonomous maneuvering, guidance to unsurveyed regions,
accurate geometric measurements, and better visualization.

Public health relevance
NARRATIVE Endoscopies are commonly performed for various diagnostic purposes, and 3D understanding is typically done in the mind of the clinician performing the procedure and analyzing the endoscopy videos. However current state-of-the-art techniques for 3D reconstruction use camera motion only and do not work well or fail entirely for real organs since they lack strong geometric features, have highly reflective mucus layers, and often deform over time. In this project, we address these challenges by explicitly modeling the reflection of light from mucus layers and by accounting for time-varying deformation to obtain 3D reconstructions of unprecedented quality.